Effects of Transcranial Magnetic Stimulation on Social Cognition, Cognitive Processing, and Functional Brain Architecture in Psychopathy

PROJECT SUMMARY/ABSTRACT
This NIMH Career Development Award will support Dr. Drew Winters at the University of Colorado School of
Medicine to conduct a trial focusing on transcranial magnetic stimulation (TMS) for intervention development in
psychopathy. Dr. Winters will enroll adults ages 18-60 years (n=60) with psychopathy to test whether inhibitory
TMS to the right dorsolateral prefrontal cortex (dlPFC) and excitatory TMS the right temporoparietal junction
(TPJ) can improve social cognition (Aim 1), cognitive processing (Aim 2) and functional brain architecture (Aim
3). The career development plan supports the research aims and includes these training goals: 1) Develop
expertise in TMS as a research tool; 2) Develop expertise in randomized controlled trial (RCT) design,
implementation and analyses; 3) Develop expertise in analysis of brain data from TMS experiments to make
causal inferences; 4) Develop expertise in psychopathic mechanisms. His mentors, Drs. Sakai, Mikulich, Oathes,
and Waller are recognized experts in TMS, neuroimaging, statistics, clinical trials, advanced computational
methods and causal inference with brain data, as well as psychopathy. The training plan and research protocol
proposed under this career development award would provide the needed experiences, skill development and
pilot data to help to launch Dr. Winters’ career as an independent scientist focusing on the neural mechanisms
underlying social cognition, cognitive processing, and functional brain architecture implicated in psychopathy
and antisocial phenotypes, along with novel treatment development.

Public health relevance
PROJECT NARRATIVE Psychopathy is implicated in a disproportionate amount of violent criminal behavior and exerts a toll on individuals, families and society; yet available treatments to date have modest efficacy. A promising and new avenue for intervention development involves targeting implicated brain regions (specifically the right dorsolateral prefrontal cortex [dlPFC] and temporal parietal junction [TPJ]) for neuromodulation using transcranial magnetic stimulation (TMS). Thus, we propose a randomized clinical trial to examine how targeted TMS to the dlPFC and TPJ may improve social cognition, cognitive processing, and brain functional connectivity patterns in those with psychopathy.